Clinical Neuroscience Research Training in Psychiatry

Project Summary
Clinical Neuroscience Research Training Program (CNRTP) in Psychiatry
This training program, now in its 20th year, is designed to meet the national goal of increasing the number of fully
trained psychiatric physician-scientists conducting clinical and translational patient-oriented research in mental health.
In order to be effective independent investigators, psychiatric physician-scientists must be fully trained in both clinical
neuroscience and modern clinical-translational research methodologies. The ever-increasing complexity of the science
and methods require that individuals receive specialized training in order to take full advantage of the rapid advances
occurring in the field. This 2-3 year program will utilize a curriculum designed to give the trainee mastery of the
fundamentals of basic molecular and cellular neurobiology, neuropharmacology, neuroimaging, psychiatric genetics and
the responsible conduct of psychiatric research in human subjects. Trainees will benefit from individualized mentorship
by members of a large and multidisciplinary group of research training faculty within the Department of Psychiatry.
The rich training environment is supported by a number nationally funded research programs / infrastructures within
the Department of Psychiatry, including the: 1) Clinical Neuroscience Research Unit, 2) National Center for
Neurobiological Study of Post-Traumatic Stress Disorder, 4) Center for the Translational Neuroscience of Alcoholism, 5)
The Yale Stress Center, 6) Neurobiological Studies Unit, 7) Neuroimaging Program (that includes PET, SPECT, fMRI, MRS,
and DTI), 8) Psychotherapy Development Research Center, 9) Program in Human Psychiatric Genetics, as well as 10) new
programs in Interventional Psychiatry, Computational Psychiatry, and Diet/Metabolism/Brain-Gut interactions. Trainees
will conduct their research studies in specialized inpatient and outpatient research facilities and specialty clinics, and the
resources from other basic science programs within the Department and Medical School will also be utilized.
For the past 60 years, the Research Faculty in the Department, and its alumni, have had an outstanding track record of
training nationally and internationally prominent researchers in psychiatry. The renewal of this application seeks
stipends for 5 postdoctoral fellows per year and will allow this program to continue to succeed in increasing the number
of fully trained, clinical-translational, patient-oriented research psychiatrists nationally.

Public health relevance
Project Narrative In its most severe and incapacitating forms, "mental illness" affects up to 2-3% of the population, and in milder forms, as high as 10-15% of the population. Given the complexity of the problem, a new generation of psychiatrists will need training in the most advanced clinical-translational research methods if breakthroughs are to emerge. Thus, the current training program will recruit and train psychiatrists as physician-scientists in the clinical-translational neuroscience of mental illness.